The Role of CD28 cosignaling molecules on anti-viral immune responses in Chronic Kidney Disease

Abstract Limiting immune-mediated damage following transplantation while maintaining protective immunity requires precise regulation of the immune system. A major challenge is the activation of alloreactive T lymphocytes, which is carefully controlled by the balance of costimulatory and coinhibitory signals T cells receive. The CD28/CTLA-4 pathway is the prototypic co-signaling pathway in T cells, with CTLA-4 co-inhibition acting as the counter-signal to CD28 costimulation as they bind the same receptors, CD80 and CD86. Immunomodulation via blockade of this pathway is a promising approach to prevent inappropriate T cell activation in the setting of transplantation. Belatacept, which binds to CD80/86, is the first costimulation blocker to be FDA approved for use in clinical transplantation and offers significantly improved long-term graft function and fewer toxicities compared to calcineurin inhibitors (CNIs). Use of Belatacept was associated with increased rates of EBV-associated post-transplant lymphoproliferative disorder (PTLD), which is normally kept under strict control by the immune surveillance activities of virus-specific CD8+ T cells. The idea that CD28-mediated signals are required for sufficient EBV-specific CD8+ T cell responses and control of viral recrudescence has recently come into question. Two recent studies have suggested that blocking CD28 is fundamentally different than blocking CD80/CD86 with regard to EBV-specific adaptive immune responses and viral control. Recently, a reagent that selectively targets CD28, while leaving CTLA-4-mediated inhibition intact, has been developed. These anti-CD28 domain antibodies have been shown to be roughly five times more potent than Belatacept against CD86- driven T cell proliferation and to be a more potent inhibitor of graft rejection when compared to CTLA-4 Ig treatment. Given the potent immunosuppressive effects of the anti-CD28 dAb, understanding the impact of selective CD28 blockade on protective immunity is an important clinical question. Additionally, this comparison has never been made in the setting of pre-transplant chronic kidney disease (CKD) in which patients have a well-documented immune dysregulation leading to increased susceptibility to infections, immune-activation-associated inflammation, and poor responses to vaccines. To this end, we plan to directly compare the effects of selective CD28 blockade vs. CTLA-4 Ig on protective immune responses to both murine cytomegalovirus (CMV) as well as MHV-68, a murine homolog of EBV, in both healthy WT mice and mice affected by CKD. Determining the precise effects of CD28 vs. CD80/86 blockade on the generation, maintenance, and functionality of CMV- and MHV-specific CD8+ T cell responses in these settings will provide mechanistic insight and inform the development of novel selective CD28 blockers for use in clinical transplantation.

Public health relevance
Narrative Limiting graft rejection while maintaining protective immunity to viral infections is a major challenge following transplantation when patients receive systemic immunosuppression. Understanding the impact of CD28 blockade-based immunosuppression on protective immunity is an important clinical question which has never been asked in the setting of pre-transplant chronic kidney disease (CKD); this is relevant because CKD patients have well-documented immune dysregulation leading to increased susceptibility to infections, immune-activation-associated inflammation, and poor responses to vaccines. The experiments proposed in this application provide extensive training opportunities to investigate the mechanisms by which CD28 vs. CD80/86 blockade affects the generation, maintenance, and functionality of CMV- and MHV-specific CD8+ T cell responses in the setting of CKD.